Modulating drug efflux transporter expression on the macrophage reservoir of HIV

Our overall objective is to identify the impact of macrophage phenotype dependent drug transporter expression
on the intracellular disposition of antiretrovirals and replication of HIV-1 in the macrophage reservoir. While the
CD4+ T cell reservoir is the primary reservoir of HIV-1, the macrophage reservoir has increased acceptance.
Macrophages are a heterogeneous cell population, and across their activity differentially express drug
transporters, resulting in differences in intracellular concentrations of antiretrovirals. Our previous work shows
higher expression of the efflux transporter MRP1 in pro-inflammatory M1 macrophages, and higher expression
of P-gp and BCRP in the anti-inflammatory M2 phenotype. The vast majority of antiretrovirals are substrates of
at least one of these transporters. Developing strategies to increase intracellular concentrations of antiretrovirals
across their spectrum of activation is necessary to combat replication in the macrophage reservoir of HIV-1.
Our overall hypothesis is that the macrophage reservoir of HIV-1 requires phenotype-specific interventions to
control viral replication. Our specific hypothesis is that macrophages across their spectrum of activation
differentially efflux antiretrovirals, resulting in altered HIV replication between polarized macrophage subsets.
This is based on our preliminary data showing altered drug efflux transporter expression across the spectrum of
macrophage activation, and data showing that inhibitors of drug efflux influence intracellular antiretroviral
concentrations and viral replication in a phenotype-specific manner. We propose two aims.
Aim 1: Characterize the impact of macrophage phenotype specific drug efflux transporter expression on
intracellular antiretroviral concentrations and HIV-1 viral replication. We hypothesize that phenotype-specific
differences in drug efflux transporters will result in altered intracellular antiretroviral concentrations and
differences in HIV-1 replication between macrophage subsets. We will utilize monocyte derived macrophages
(MDM) differentiated from healthy donors. Polarized macrophages will be treated with antiretrovirals and infected
with HIV-1. Intracellular antiretroviral concentrations and viral replication will be assessed between macrophages
populations across multiple timepoints. Antiretroviral and viral replication kinetics will be assessed. Aim 2: Identify
strategies to increase intracellular antiretroviral concentrations in macrophages across their spectrum of
activation. We hypothesize that increasing intracellular antiretroviral concentrations in the macrophage reservoir
of HIV will require phenotype specific strategies. We will utilize MDM and both directly block the activity of drug
transporters and modulate the activity of cell signaling pathways known to control transporter expression,
including NF-κB and JNK. The successful completion of this project will result in new insights into the causes of
heterogeneity of the macrophage reservoir of HIV-1 and identify targets to increase antiretroviral concentrations
in macrophages across their spectrum of activation. Future work will utilize these identified targets as a means
to develop novel strategies to combat HIV-1 replication in the macrophage reservoir of HIV-1.

Public health relevance
HIV cannot be eliminated from the body due to its ability to reside in cells including T cells and macrophages. Due to differences in macrophage function, it is necessary to develop approaches to increase the amount of drugs to fight HIV in macrophages. This goal of this research is to identify the factors that influence the amount of HIV drugs in macrophages, and develop approaches to get more drug into macrophages.